Nutritional regulation of pathogenesis in Staphylococcus aureus

7. Project Summary/Abstract
Staphylococcus aureus is the leading cause of life threatening skin and soft tissue infections, osteomyelitis,
pneumonia and endocarditis, but spends much of its time as a commensal bacterium, colonizing 30-50% of the
population asymptomatically. Vaccine candidates show promise for highly susceptible populations, but a
general, effective approach to preventing staphylococcal infections remains elusive. Moreover, the mechanistic
basis for the commensal-to-pathogen switch is complex and remains unsolved, but changing nutrient
availability in the various environments of the human host likely plays an important role in informing the
bacterium's decision to switch between lifestyles. The global transcriptional regulator CodY is activated by
isoleucine, leucine, valine (ILV) and GTP, and adjusts metabolism and virulence gene expression. Our
preliminary data indicate that CodY activity is not binary (i.e., on or off). Rather, CodY can sense a range of
concentrations of ILV and GTP to generate a hierarchical transcriptional and physiological response. That is,
under conditions of increasing ILV and GTP depletion, toxins and spreading factors are sequentially induced.
Additional work by our lab has shown that CodY controls nearly all of the known virulence genes in conjunction
with three of the most important regulators of S. aureus virulence: the Sae two-component system, the
regulatory protein Rot, and the Agr quorum-sensing system. In collaboration with staphylococcal biologists
Christopher Montgomery (Nationwide Children's Hospital), Victor Torres (NYU School of Medicine), and Taeok
Bae (Indiana School of Medicine-NW), we will unravel the mechanistic basis by which CodY ties virulence to
nutrient availability. We will use LC-MS based metabolomics, confocal microscopy, classical molecular
genetics and biochemistry to (i) determine the mechanisms by which CodY regulates the expression of the sae
locus, and (ii) determine how nutrient availability alters the activity of the Sae Two Component System.
Additionally, we will explore mechanistically how CodY constrains virulence during S. aureus-immune cell
encounters as well as during skin and soft tissue infection using a mouse model of S. aureus dermonecrosis.
Understanding how nutrient signals are integrated into the virulence regulatory network by factors like CodY
can potentially inform the rational design of novel antimicrobials that limit host damage, desperately replacing
obsolete antibiotics in an era of pan-resistance.

Public health relevance
8. Project Narrative. Staphylococcus aureus is a bacterium that can persist in and on our bodies, carrying out a harmless existence before turning harmful and causing life threatening infections. CodY is a regulatory protein for turning on and off the genes that mediate this lifestyle switch, but knowledge about how CodY orchestrates this developmental process as a function of available nutrients is very limited. This proposal aims to determine mechanistically how S. aureus uses CodY and key nutrients to induce the physiological changes and factors required to convert benign bacteria to dangerous pathogens, revealing potential new avenues for developing antimicrobials that limit persistence and disease at a time when many antibiotics are ineffective.